Ocular Sequelae and Intervention in a Rat Model of Blast Overpressure Polytrauma

Military personnel are frequently exposed to blast-induced shock waves (acoustic blast overpressure,
ABO), with intensities sufficient to cause polytrauma, of which traumatic brain injury (TBI) is a common
component. Relatively little is known about the structural or functional effects on the retina per se
induced by ABO exposure, which initially may be occult and not manifest significantly until weeks to
months post-blast. This project focuses on providing an understanding of the etiology and treatment o f
ABO-associated retinal and visual system defects, as well as attendant CNS and motor system damage
and dysfunction. Prior studies have implicated oxidative stress in the pathophysiology of ABO-induced
polytrauma, suggesting that antioxidants may provide an effective therapeutic intervention against such
injury. In addition, neuroprotective agents have shown promise for intervening in TBI, using a rat model
employing direct mechanical impact to the brain (i.e., the “lateral fluid percussion” (LFP) model). Herein,
we directly compare our rat ABO model of primary blast injury against the complimentary LFP TBI model,
and show “molecular signature” linking the two models, suggesting common underlying mechanisms for
the observed pathologies in both. Using both models, we will test the efficacy of a novel, blood-brain-
barrier permeable multifunctional antioxidant (MFAO (“HK-2”)) and a neuroprotectant
(phenoxybenzamine (“PBZ”)), alone and in combination, to limit the severity of polytrauma. AIM 1 will
evaluate the therapeutic efficacy of HK-2 and PBZ in preventing or attenuating ABO-induced polytrauma
(visual, cognitive and neuromotor deficits, and CNS structural abnormalities). In an analogous manner,
AIM 2 will evaluate the therapeutic efficacy of HK-2 and PBZ in preventing or attenuating LFP-induced
polytrauma. State-of-the-art methods for assessing visual, cognitive, and neuromotor function, as well
as retina and brain structure, will be employed, along with correlative biochemical, immunological, and
histological methodologies. Relevance to Active Military and Veterans' Healthcare Issues: TBI is the
signature injury of the conflicts in Iraq and Afghanistan (OEF/OIF). Currently, there are no effective
treatments or prophylactic interventions to minimize or prevent ABO-induced polytrauma, including TBI
and attendant vision deficits. With thousands of active military personnel being subjected to such injury-
provoking conditions on a recurrent basis, this presents a significant unresolved healthcare issue for
active military personnel and Veterans. PIs and Environment: The Site 1 PI (Fliesler) has a >35-year
record of productivity in eye/vision research, involving animal models of retinal degenerations and
employing a diversity of molecular/cell biological methodologies. He is Director of the Vision Research
Center and a Research Career Scientist Award (RCSA) recipient at the Buffalo VAMC, and an endowed
chair Professor/Vice-Chair/Research Director in the Dept. of Ophthalmology at the University at Buffalo
(UB). He has the ABO rat model and HK-2 in-house. A UB collaborator (Poulsen) has the LFP model
established in his lab, has utilized the rat LFP TBI model for >15 years, and has investigated multiple
neuroprotective agents using this model. He is a Professor of Translational Neuroscience and a member
of the Neurosurgery Department, and has extensive experience in both functional behavior and cognitive
assessments relative to the rat TBI model. The Site 2 PI (Pardue) is a RCSA recipient at the Atlanta
VAMC, Assoc. Director of Scientific Projects at the Atlanta VA Rehab R&D Center of Excellence, and
Professor of Biomedical Engineering at Georgia Institute of Technology, with >25 years of experience
in eye/vision research, particularly as involves electrophysiological and behavioral diagnostic methods.
The PIs have an established and ongoing collaborative relationship, and have superlative resources and
supportive environments to ensure the successful execution of this project.

Public health relevance
Polytrauma, including traumatic brain injury (TBI), following acoustic blast overpressure (ABO) exposure is common in military personnel actively deployed in war zones. There are no effective treatments or preventative interventions for such injuries. Here, we propose preclinical studies to test the efficacy of a novel antioxidant and, separately, a neuroprotective agent, to minimize the attendant structural and functional damage to the retina and brain, as well as neuromotor system, pursuant to ABO (or TBI-inducing) exposure. The potential benefits to the Military are: 1) preservation of functional visual, cognitive, and motor skills in at-risk military personnel; 2) psychological and quality-of-life benefits to those affected personnel, who otherwise would suffer polytrauma sequelae; and 3) marked reduction in the healthcare burden placed on the Department of Veterans Affairs for both the near- and long-term care of affected personnel. These objectives are integral to the VA’s healthcare mission.